NIDCR DIR Clinical Training

In FY17, the NIDCR DIR Clinical Research Fellowship program supported the training of six dentists in clinical and translational research studying diseases of the craniofacial systems, Drs. Andrea Burke, Rashmi Mishra, Monisha Billings, Taro Mukaibo, and Blake Warner, Fahad Kidwai. One trainee participated in the DPH residency. The trainees participated in the NIDCR clinical research curriculum and in the NIDCR Fellow's Retreat. Support was provided for scientific meetings to present research projects and interact with scientific colleagues (e.g. American Association for Dental Research). The trainees also attended NIDCR DIR and NIDCR sponsored seminar series, as well as NIH-wide Clinical Research Seminars.